Functional, structural, and computational consequences of NMDA receptor ablation at medial prefrontal cortex synapses

Project Summary
Schizophrenia is a psychiatric disorder that affects approximately 24 million people worldwide and can lead to
emotional distress, disability, and reduced lifespan. Cognitive dysfunction is the best predictor of patient outcome
in schizophrenia, yet current pharmacological treatments often fail to treat cognitive symptoms such as working
memory deficits. In addition, it is not yet understood how certain biological abnormalities associated with
schizophrenia – for example, decreased cortical expression of N-methyl-D-aspartate (NMDA) receptors – lead
to changes in brain circuit function, especially when these abnormalities progress over the course of the lifespan
and may be affected by in vivo compensatory mechanisms in the brain. My proposed research seeks to
investigate the effects of chronic NMDA receptor loss upon synaptic function and architecture in the prefrontal
cortex, and its potential implications for neural network activity and working memory deficits. Specifically, this
computational psychiatry project will focus on examining functional and structural abnormalities at excitatory-to-
excitatory synapses, which produce the reverberant neural activity that allows information to be retained in
working memory and are particularly vulnerable to disconnection in schizophrenia. I will measure functional
changes in excitatory-to-excitatory synaptic strength using ex vivo slice electrophysiology in prefrontal cortex
pyramidal neurons, and I will examine structural changes in dendritic spine morphology and density in the same
neurons using confocal imaging. I will then leverage insights gained from these electrophysiology and imaging
experiments to build and test predictions regarding stability and synchrony of brain activity in a spiking network
model.

Public health relevance
Project Narrative This computational psychiatry proposal aims to address significant gaps in our understanding of how prefrontal cortical N-methyl-D-aspartate (NMDA) receptor loss contributes to functional and structural synaptic changes in schizophrenia. Integrating electrophysiological and morphological analysis of pyramidal neurons will provide valuable insights for understanding how excitatory synaptic abnormalities lead to network-level pathophysiology, with implications for loss of cognitive function. The long-term goal of this proposal is to improve our understanding of brain circuit disruption in schizophrenia, and eventually guide the development of targeted neuromodulation- based therapies to repair neural circuits and restore working memory in patients.